Climate & Health Actionable Research and Translation Center

CHART: OVERALL - PROJECT SUMMARY
According to the United Nations, 87% of the U.S. population and 68% of the world population are projected to
live in cities by 2050, and climate change will have significant impacts on the health and wellbeing of urban
populations especially in under-resourced communities through various pathways. For example, the spatial
variation in ambient temperature has been shown to result in heat exposure disparities associated with low-
income minority communities. The Emory Climate & Health Actionable Research and Translation (CHART)
Center aims to become a hub that will advance and translate research on climate risks to protect the health of
under-resourced urban populations. Atlanta, with its unique environmental and health challenges, historical
legacy, and longstanding partnerships with community and academic stakeholders, is an ideal location for
CHART's central research theme of lowering climate-related disease burdens in under-resourced urban
communities. CHART's mission is to generate new knowledge about the health risks associated with climate
change in urban areas, particularly those related to heat exposure, and to translate this knowledge into action
through equitable partnerships that enhance health. The center has four aims: (1) to develop resources to
support CCH research and connect with NIH's CCH Community of Practice; (2) to conduct action-oriented and
transdisciplinary CCH research towards the design of future interventions and policy; (3) to leverage the
CHART translational research framework to sustain and enrich relationships with community partners; and (4)
to advance the growth of CCH research through training and mentorship. By providing infrastructural support,
conducting novel research, increasing research capacity, strengthening established community partnerships,
and serving as a hub for identifying innovative approaches to address climate change-induced health risks
such as heat exposure, CHART will foster mutually beneficial partnership and collaboration with community
stakeholders while also attracting talented researchers to sustain and expand the CCH Community of Practice.
Ultimately, these efforts will lead to tangible improvements in the health outcomes of under-resourced urban
communities in Atlanta, and the center building experience will benefit other cities nationally and worldwide in
their pursuit of mitigating the health impact of climate change.

Public health relevance
CHART: OVERALL – PROJECT NARRATIVE We propose to establish Emory Climate & Health Actionable Research and Translation (CHART) Center. By providing infrastructural support, conducting novel research, strengthening established community partnerships, and increasing research capacity, CHART will become a hub that will advance and translate research on climate risks to protect the health of under-resourced urban populations.